Metabolic control of human endothelial development via the COUP-TF/1-deoxysphingosine axis

PROJECT DESCRIPTION
Vascular and lymphatic systems have emerged as attractive therapeutic targets in a variety of diseases.
Stimulating angiogenesis accelerates wound healing and tissue regeneration after myocardial infarction whereas
inhibition of angiogenesis suppresses tumor growth1 and progression of intraocular neovascular diseases.
Likewise, stimulating lymphangiogenesis aids in the treatment of secondary lymphedema, prevents
atherosclerosis and could promote cancer immunotherapy. Endothelial cells (ECs) are key components of
arterial, venous, and lymphatic vasculatures. Studies in mice identified the transcription factor NR2F2, also
known as COUP-TFII, as the key regulator of EC fate. However, major gaps exist in our knowledge of the cellular
and molecular mechanisms by which NR2F2 regulates EC specification. Which EC subsets, developmental
transitions and molecular networks are targeted by NR2F2 is unknown. NR2F2 and its homolog NR2F1 are
members of the nuclear hormone receptor (NHR) family of transcription factors. NHR activities are controlled by
small molecules derived from endogenous metabolism or diet. Recently, we identified 1-deoxysphingosines as
natural ligands for NR2F1/2. Although 1-deoxysphingosines have been detected in tissues, no physiological
roles have yet been proposed for these metabolites - they are considered toxic byproducts of sphingolipid
biosynthesis resulting from mutations in subunits of the SPT complex. Our study is the first to suggest that these
metabolites have a physiological function as regulators of NR2F1/2-mediated transcription. The mechanistic
understanding of how NR2F1/2:1-deoxysphingosine axis regulates EC development would yield knowledge
needed to modulate blood/lymphatic vessel development in research and clinical settings. In this proposal, we
will (1) define the cellular and molecular networks regulated by NR2F1/2 and its ligand, 1-deoxysphingosine,
during arterial venous, and lymphatic specification of hESCs, (2) delineate molecular pathways that modulate 1-
deoxysphingosine synthesis and uptake and identify major physiological sources of this metabolites in vivo, and
(3) define the structure of ligand-bound NR2F2 LBD and validate ligand-receptor interactions. The work proposed
is significant because it will identify molecular pathways that modulate NR2F2 transcriptional activity thus
contributing to an understanding how NR2F2-mediated transcriptional networks regulate development and
physiology of vascular and lymphatic systems. This knowledge will be instrumental for developing ligand analogs
that can act as chemical modulators of NR2F2 activity under normal and disease conditions. Our approach is
innovative because we will develop new concepts and methodologies that could be adapted to understand the
molecular bases of NHR-mediated transcription and to search for ligands of other orphan NHRs.

Public health relevance
PROJECT NARRATIVE The vascular and lymphatic systems are essential for delivering oxygen and nutrients to organs, removing waste products and regulating tissue fluid homeostasis and immune cell trafficking. We propose to define the role of nuclear hormone receptor NR2F1/2 in the specification of arterial, venous and lymphatic endothelium, reveal the molecular mechanisms that regulate ligand-dependent NR2F1/2 transcription and provide a structural basis for designing synthetic agonists/ antagonists to modulate NR2F1/2 activity. The proposed research is relevant to public health because a thorough understanding of transcriptional networks driving endothelial development is critical for designing regenerative treatments to repair blood and lymphatic vessels damaged by congenital conditions or disease. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing of fundamental knowledge that will help reduce the burdens of illness and disability.